Redox Regulation of O-GlcNAcylation Signaling in the Pathogenesis of Alcoholic Fatty Liver Disease

PROJECT SUMMARY
Alcoholic fatty liver disease (AFLD) is a major cause of chronic liver disease. Globally, AFLD accounts for 0.9%
of total mortality and 0.6% of disability-adjusted life years and remains a public health problem worldwide.
Despite its profound health and economic impact, the AFLD management remains challenging due to the lack
of detailed understanding of determinants of its pathogenesis and progression. The goal of this project is to
elucidate a novel role of redox-modulated hepatic O-GlcNAc signaling in alcohol-induced liver injury, and
thereby identify potential novel preventive, diagnostic and/or therapeutic targets against AFLD. Oxidative
stress is implicated to play a central role in many pathways involved in the initiation and progression of AFLD.
Hepatic glutathione (GSH) functions in maintaining cellular redox homeostasis. Intriguingly, chronic GSH
deficiency in mice harboring a global disruption of the glutamate-cysteine ligase modifier subunit (Gclm) gene
confers protection against alcohol-induced steatosis. Molecular and metabolomics studies indicate that the
hepatoprotective effect of low GSH is linked to activations of AMPK signaling pathway and NRF2 antioxidant
response, and reprogramming of hepatic metabolism that benefits the maintenance of cellular redox and
metabolic homeostasis. Multiomics analyses imply that post-transcriptional mechanisms play a significant role
in mediating low GSH-elicited metabolic adaptation upon ethanol exposure. O-GlcNAcylation of protein is a
prevalent form of post-translational modification (PTM), where a single O-linked N-acetylglucosamine (O-
GlcNAc) moiety is added to nuclear, cytoplasmic and mitochondrial proteins. This process is controlled by a
pair of O-GlcNAc cycling enzymes, O-GlcNAc transferase (OGT) and O-GlcNAcase (OGA). In the liver, O-
GlcNAc signaling has been shown to serve as an important mechanism for nutrient and stress sensing and
subsequent regulation of liver cellular homeostasis. Aberrant O-GlcNAcylation has been implicated in hepatic
insulin resistance, fatty liver disease and associated fibrosis. To date, little is known about the role of O-
GlcNAcylation in AFLD pathogenesis. Our preliminary studies show that, in GSH-deficient Gclm-null mouse
livers, chronic-binge ethanol feeding induced beneficial changes in global O-GlcNAylation and associated
cellular pathways and signaling proteins. This project will expand upon these provocative findings and test the
hypothesis predicting that adaptive O-GlcNAc signaling driven by chronic oxidative stress (due to GSH
deficiency) in the liver protects against alcohol-induced liver injury. We propose to (1) utilize the Gclm-null
mouse model to examine ethanol-induced changes in O-GlcNAcylation and phosphorylation modifications of
the liver proteome and substrate targeting of O-GlcNAc cycling enzymes, and (2) evaluate the functional
impacts of top candidate protein-O-GlcNAcylations in ethanol-associated stress response in human HepaRG
cells. The proposed study will be the first examination of in vivo interplay between hepatic redox status and O-
GlcNAcylation signaling in the context of alcohol induced liver injury.

Public health relevance
PROJECT NARRATIVE The goal of this project is to identify novel targets involved in protection against alcoholic fatty liver disease (AFLD) by elucidating a novel role of redox-modulated hepatic O-GlcNAc signaling in AFLD pathogenesis. Our preliminary studies show that chronic-binge ethanol feeding induces differential changes in liver global O- GlcNAcylation (a prevalent form of post-translational modification) in a mouse model of chronic oxidative stress, which may serve as a protective mechanism against alcohol-induced liver injury. We propose to examine ethanol-associated changes in hepatic O-GlcNAcylation signaling and elucidate key signaling events that are mechanistically linked to hepatoprotection.